PRECISION METABOLIC THERAPY OF p53 MUTANT TRIPLE NEGATIVE BREAST CANCERS

PROJECT SUMMARY
The Cancer Genome Atlas (TCGA) studies have identified p53 as the most frequently mutated gene in breast
cancer. In particular, 80% of triple-negative breast cancers (TNBCs) harbor p53 mutations. However, there is no
specific therapy available for treating p53-mutant TNBC. Cancer cells have distinct metabolic needs compared
to normal cells, and this observation has spurred the development of small molecule inhibitors to target metabolic
enzymes that are specifically needed by cancer cells for survival. Notably, although there is evidence to support
a role for metabolic pathway deregulation in breast cancer growth, the metabolic dependencies of p53-mutant
TNBC growth and metastasis have not been comprehensively identified. Therefore, to specifically identify the
metabolic dependencies of p53-mutant TNBCs, we performed an innovative and unbiased large-scale in vivo
short-hairpin RNA (shRNA) screen by targeting 2000 genes with known metabolic functions. With this screen,
we identified N-acylsphingosine amidohydrolase 1 (ASAH1) as an enzyme that is necessary for tumor-forming
ability and metastatic activity of p53-mutant TNBCs. Additionally, we identified two small molecule inhibitors of
ASAH1 with potent anti-p53-mutant TNBC activity, thereby indicating that ASAH1 is a potential drug target for
the treatment of p53-mutant TNBCs. The central hypothesis of this proposal is that p53-mutant TNBC cells
depend upon ASAH1 for their survival, and thus, ASAH1 inhibition selectively eradicates p53-mutant TNBCs.
Our overall objectives are to determine the role of ASAH1 in driving p53-mutant TNBC tumor growth and
metastasis, understand the mechanism underlying the dependency of p53-mutant TNBCs on ASAH1, and
evaluate the translational potential of small molecule ASAH1 inhibitors for treating p53-mutant TNBC. In Aim 1,
we will establish the role of ASAH1 in p53-mutant TNBC tumor growth and metastasis using a series of
complementary, state-of-the-art mouse models that recapitulate characteristic features of TNBC growth and
metastasis. These include a highly innovative humanized mouse model with a human immune system. In Aim
2, we will test our hypotheses that p53 represses ASAH1 activity by sequestering this protein in the nucleus.
Additionally, based on our new preliminary results, we will confirm whether loss of ASAH1 activates the glucose
starvation response, leading to AMP kinase pathway activation via a ceramide-mediated reduction in expression
of the glucose transporter GLUT1 on the cell membrane. In Aim 3, we will evaluate the translational potential of
ASAH1 inhibitors in immunocompromised and immunocompetent humanized mouse models of p53-mutant
TNBC, either alone, or based on our preliminary findings, in combination with BET domain inhibitors. Collectively,
we predict that the results of the experiments proposed in this application will establish ASAH1 as an important
vulnerability inherent to p53-mutant TNBC cells, elucidate the mechanism underlying the dependency of p53-
mutant TNBCs on ASAH1 activity, and evaluate a novel therapeutic approach for treatment of p53-mutant TNBC.

Public health relevance
PUBLIC HEALTH SIGNIFICANCE One in eight US women is expected to develop an invasive breast cancer in her lifetime, and among the various breast cancer subtypes, triple-negative breast cancer (TNBC) carries the worst prognosis, in part, due to a lack of effective therapies. Mutations in p53 are present in over 80% of TNBCs, and we have found that ASAH1 is required for tumor and metastatic growth of p53-mutant TNBCs. The results of the experiments proposed in this application will establish the role of ASAH1 in promoting p53-mutant TNBC tumor growth and metastasis, as well as investigate the translational potential of ASAH1 inhibitors for p53-mutant TNBC therapy.